Strategies to improve Utilization of Post-overdose Evidence-based Risk mitigation among Non-fatal Overdoses in VA (SUPER NOVA)

Background: Drug overdose is a leading cause of death, accounting for 70,630 deaths in the United States
(US) in 20193. The majority of drug overdoses involve opioids, and opioid-involved stimulant deaths are rising
with 3 out of every 4 cocaine-related deaths involving opioids and 53% of psychostimulant-related deaths
involving opioids7. Drug overdose mortality among Veterans mirror these trends5,6. In Massachusetts, among
individuals who died of an opioid overdose, 1 in 6 had a non-fatal overdose in the preceding 12 months17.
These non-fatal overdoses serve as a promising target for opioid overdose prevention efforts, especially for
evidence-based treatments such as medications for opioid use disorder (MOUD). The increase in stimulant-
involved opioid overdoses also highlights the need to investigate strategies to improve uptake of evidence-
based treatments for stimulant use disorders.
Significance: In March 2019, the VHA Office of Mental Health and Suicide Prevention released a national
clinical note template, the Suicide Behavior and Overdose Report (SBOR). The SBOR standardizes the
reporting process, enhances the visibility of suicide and overdose events in the medical record, and is intended
to improve clinical care after these events (e.g., by incorporating risk factors for overdose and strategies to
mitigate risk, including referrals for care). However, the SBOR is currently mandated for intentional overdose
and only recommended for unintentional overdose. Moreover, it is unclear the extent to which it is being used
and whether its use improves post-overdose care as intended.
Innovation and Impact: The proposed study will characterize non-fatal opioid-, stimulant-, and combined
opioid and stimulant overdoses among VHA patients and the extent to which they receive recommended post-
overdose care. Given that the SBOR will soon be mandated for all overdoses, and to ensure that VHA is doing
everything it can to prevent overdose mortality among Veterans, it is critical to understand whether the SBOR
is improving post-overdose care as intended and if additional strategies may be needed.
Specific Aims: The proposed study will pursue the following specific aims:
Aim 1: Characterize non-fatal opioid and/or stimulant overdoses within VHA and patient-, prescriber-, and
setting-related factors associated with post-overdose treatment utilization.
Aim 2: Describe utilization of the SBOR among providers of patients with non-fatal opioid and/or stimulant
overdoses and associations between SBOR use, post-overdose treatment utilization, and treatment outcomes.
Aim 3: Identify barriers and facilitators of post-overdose care and ways to improve it via interviews with VHA
patients, patients’ concerned others, and treatment providers.
Methodology: The Reach, Effectiveness, Adoption, Implementation, and Maintenance—RE-AIM—framework
will guide our study. Aim 1: VHA patients with non-fatal overdoses will be identified using Corporate Data
Warehouse (CDW), Community Care, and Medicare data from Fiscal Years 2014 to 2021 (FY2014-2021).
Regression models will describe patient, prescriber, and setting factors associated with post-overdose care.
Aim 2: Using CDW, Community Care, and Medicare data combined with VA Mortality Data Repository data,
primary analyses will examine whether providers’ SBOR use is associated with patients’ post-overdose
treatment utilization and reduced mortality using marginal structural Cox mediational models. Aim 3: Up to 60
total interviews will be conducted with VHA patients who experienced a non-fatal overdose, their concerned
others, and VHA providers who documented a non-fatal overdose. Rapid and in-depth qualitative analytic
approaches will be used; the former allows for rapid provision of actionable feedback to operations partners.
Next Steps/Implementation: Our research team has strong operational partnerships and helped develop and
implement the SBOR. Our team will ensure that findings are quickly translated to improve post-overdose care.

Public health relevance
Drug overdose is the leading cause of accidental death in the United States. While opioid overdoses comprise most overdose deaths, stimulant overdose deaths are rising. This project examines an important but missed opportunity—non-fatal overdose—to improve Veterans’ health care and health outcomes. To improve post- overdose care, the Veterans Health Administration developed a national clinical note template—the Suicide Behavior and Overdose Report (SBOR)—which is currently recommended for unintentional overdoses (majority of overdoses) but will soon be mandated. However, the SBOR is currently optimized to address opioid, not stimulant, overdose. Also, despite the promise of the SBOR to improve post-overdose care, unknown is the extent to which clinicians are using it and whether its use improves post-overdose care as intended. This project will fill a great need to understand how to improve the SBOR and, ultimately, post- overdose treatment for Veterans who have non-fatal overdoses and remain at high risk for poor outcomes.